Career Training in Reproductive Biology

Abstract / Project Summary
Reproductive health is the window to overall health and offers enormous opportunities and challenges for high-
quality interdisciplinary research and careers. The goal of this renewal is to continue the efforts of the Career
Training in Reproductive Biology (CTRB) Program to train exceptional predoctoral students for diverse
scientific careers in the reproductive sciences. Funds are requested to train four predoctoral students per year
in a dual program consisting of two main parts. First, to prepare for a research career, students will engage in
rigorous, hypothesis-based scientific laboratory work in reproductive biology. Second, to prepare students for
varied career paths, they will complete a University of Michigan-sponsored Certificate program or other
structured career development activities to hone skills in teaching, translational research, public policy,
biotechnology, entrepreneurship, biotechnology or other areas of their choosing. These career development
programs were specifically designed to dovetail with graduate work to prepare students with the qualitative and
quantitative skills needed for careers in specific disciplines. This innovative program addresses the needs of
reproductive biology trainees in a way unlike any other program at the University of Michigan. Ten select
faculty mentors, who are highly-recognized scientists with a passion for and extensive combined experience in
predoctoral education, enthusiastically comprise the CTRB Program faculty. Trainees are drawn from
exceptionally strong graduate programs in biomedical sciences, biomedical engineering and environmental
health sciences. Specific training activities include formal courses (Mammalian Reproductive Physiology,
statistical analyses/experimental design, Responsible Conduct of Research, Rigor and Reproducibility),
participation in a structured mentoring workshop with their preceptor, scientific communication and
grantsmanship training, monthly mentored trainee research presentations, group discussions of laboratory
management, two annual symposia in reproductive sciences and yearly meeting with the Executive
Committee. Trainee input has and will continue to actively shape the training program, including via
anonymous surveys. Trainees and mentors submit formal competitive applications that are reviewed and
required for appointment to the CTRB Program. The CTRB Program is monitored through active engagement
of faculty and trainees in program development, and by an experienced internal advisory committee. These
mechanisms ensure program responsiveness to demands of a continuously-evolving research environment
and changing trainee needs.

Public health relevance
Project Narrative This training grant will increase the number of scientists trained in reproductive biology, and prepared for a variety of career positions. This is important as it prepares scientists to participate in basic research, translational work on health and disease, education, entrepreneurship and public policy. Individuals with expertise in reproductive biology in combination with relevant career skills are of value to public health and this is one of the few research centers that stresses this combination in our training.